IGF::OT::IGF : NIH Pain Consortium Centers of Excellence in Pain Education. N01DA-15-4431POP: September 18, 2015 - September 17, 2017. PURPOSE: To exercise Option Period 1 (Contract Year 2),

The Contractor will develop content to be used for the creation of online interactive case-based learning tools. The Contractor will implement the learning tools in its learning environment, assess its materials, and disseminate the findings from this assessment. Further, the Contractor will be encouraged to collaborate with other CoEPEs and entities with the goal of promoting improved pain education.